PHARMACOKINETICS/SAFETY OF MULTIDOSE 256U87 IN HIV INFECTED PATIENTS

This study is designed to explore the pharmacokinetic parameters of BW256U287 (acyclovir prodrug) in HIV infected men and women with fewer than 50 CD4+ cells and whether blood levels of acyclovir that will inhibit cytomegalovirus can be achieved.